RESTORATION OF FIRST PHASE INSULIN SECRETION ON PULSATILE SECRETION IN NIDDM

The specific aim of the current studies is to determine if pulsatile insulin secretion can be restored in patients with non-insulin-dependent diabetes mellitus (NIDDM) if the storage pool of insulin in beta-cells is restored by overnight inhibition of insulin secretion using somatostatin and insulin infusion.